Role of Epac1 in the Pathogenesis of Pulmonary Fibrosis

PROJECT SUMMARY
The overall objective of this proposal is to delineate the role of the exchange protein directly activated by cAMP
(Epac1) in idiopathic pulmonary fibrosis (IPF) disease. IPF is characterized by progressive scarring and fibrosis
of the lungs that results in life-threatening complications such as respiratory failure. Unfortunately, there is no
cure for IPF, and our aging world population requires a vast majority of new therapeutic targets and strategies
for treating patients with this fatal disease.
Most studies in fibrosis focused on increased cAMP to inhibit fibroblast proliferation and differentiation through
the PKA pathway, however, neither the regulation of the expression nor the contribution of Epac1 to IPF
pathophysiological processes are well defined. Thus, it is interesting to direct the research by specifically
regulating the actions of the Epac enzymes independently of PKA in IPF. Recently, the compound AM-001 has
been identified and characterized as a novel and potent Epac1 pharmacological inhibitor. AM-001 selectively
inhibits Epac1 catalytic activity and displays cardioprotective properties. Such findings reflect the need to assess
the key role of Epac1 and its specific inhibitor AM-001 in pulmonary fibrosis (PF) disease. Our preliminary
studies show that the expression of Epac1 is significantly increased in lung tissue from IPF patients, IPF diseased
fibroblasts, and bleomycin (BLM)-challenged mice compared to controls. Furthermore, Epac1 deficiency mice
are protected against BLM induced-lung injury and fibrosis. Furthermore, the knockdown and inhibition of Epac1
by AM-001 attenuate normal and IPF fibroblasts proliferation and the expression of pro-fibrotic markers, TGFβ
and interleukin-6 (IL-6). In addition, AM-001 significantly decreases lung fibrosis in vivo in the BLM-induced PF
mouse model. RNA sequencing data analyses show key components of the pro-fibrotic genes signature of IPF
in AM-001-treated NHLF cells. Based on these data our overall hypothesis is that Epac1 is an important regulator
of the fibroblast's pathological state in PF and that Epac1 can serve as a potential therapeutic target by AM-001
for PF disease. In this proposal, we will extend these preliminary findings by testing the following specific aims:
Specific Aim 1: To define the expression pattern of Epac1 in humans and mice with PF.
Specific Aim 2: To define the mechanisms of Epac1 function in fibroblast activation.
Specific Aim 3: To evaluate the effectiveness of a novel Epac1-specific inhibitor AM-001 in a mouse model of
pulmonary fibrosis. Collectively, the proposed studies will help increase our understanding of Epac1 role in lung
remodeling associated with aged-PF pathogenesis and may lead to the identification of new potential targets to
block the progression of this deadly disease.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a chronic, aging-associated lung disease characterized by the scarring of lung tissues, shortness of breath, and high mortality due to respiratory failure. This proposal is highly relevant for understanding the role of Epac1 protein in pulmonary fibrosis, and evaluate a small compound product to specifically inhibit Epac1. This proposal will lay the groundwork for developing a new therapy for the treatment of IPF.